Research Education Core (REC)

PROJECT SUMMARY – RESEARCH EDUCATION CORE
The Boston Health Equity & community-Aligned Learning Health System (Boston HEALHS) Research
Education Core (REC) will support a diverse cadre of scientists to gain skills, expertise, and experience in the
learning health system (LHS) competencies, as applied within a safety net system. The REC will provide
comprehensive yet individualized mentorship and training in LHS competencies to embedded LHS scientists,
building on and adapting existing didactic and experiential educational resources across an academic safety
net health system. The REC unites hospital systems, research, and education leaders, providing LHS
scientists with connections to leaders across the academic and health system. The REC will be responsible for
recruiting internally and externally diverse early and mid-career MD or PhD faculty who possess foundational
research training that prepares them for embedded LHS research, leveraging evidence-informed recruitment
and retention equity best practices and institutional commitments to support their long-term work in our safety
net system; two people per year will be recruited as LHS scientists. Additionally, REC will provide customized
career, education, and research mentorship for the LHS scientists through longitudinal mentoring teams to
prepare them for careers as embedded LHS scientists. Each LHS scientist will be connected with a mentorship
team tailored to their interests. The mentorship structure will be anchored by a paired team – a primary
research mentor and a primary health system mentor. The paired approach will ensure breadth and depth of
exposure to both research and health system perspectives. Scientists will work with their primary mentorship
team to craft an individual development plan (IDP) that addresses career goals, educational plans, and
research projects. Further, REC will facilitate an individualized curriculum in LHS science that combines direct
instruction from experts in each of the LHS competencies, experiential learning, and access to didactic
offerings covering all major elements of the Patient Centered Outcomes Research Institute methodology
standards. The overarching goal of the LHS scientist training program is to expand expertise and capacity in
the LHS competencies through offering cross-disciplinary, specialty agnostic, immersive methodologic training
and providing networking, support, and mentorship to promising early career and mid-career faculty through
the LHS scientists program. Our curricular offerings will provide the resources that the diverse LHS scientists
joining Boston HEALHS will require to meet the goals of learning and readiness for an impactful, independent
research career.